Alternative Ribosomes & Antibiotic Tolerance in Mycobacteria

Summary
Changes in abundance of zinc, an essential nutrient but toxic at high concentrations, necessitates
adaptive mechanisms in mycobacteria. Under zinc-rich conditions, mycobacteria synthesize
ribosomes with a set of ribosomal (r-) proteins containing the zinc-binding CXXC (C+) motif, while
zinc starvation induces paralogs of these proteins called C- (for the lack of CXXC motif) as
replacements in the 70S ribosome. Evidence of C+ to C- ribosome remodeling is reported in Mtb from
chronic lung infections in mice and humans. Clinical relevance of ribosome remodeling is supported
by greater antibiotic resistance in the C- than C+ ribosomes, highlighting the challenges in using
ribosome targeting drugs in TB therapy. Previously, we solved the structures of C+ and C- ribosomes
to decipher the mechanism of their differential antibiotic resistance. We discovered the C- ribosome
as the preferred target of mycobacterial protein Y (Mpy). Mpy is a member of highly conserved family
of bacterial protein Y, which binds to the decoding region of the ribosome, thereby hibernating non-
translating ribosomes as 70S monosomes in growth arrested cells. The structure identified two
distinct drug resistance mechanisms associated with the C- ribosome. Aminoglycoside resistance is
largely associated with the preferential binding of Mpy to the decoding center of the C- ribosome,
which directly impacts the streptomycin and kanamycin binding pockets within the C- ribosome.
Unlike aminoglycosides, tolerance to spectinamides is a direct consequence of the structural changes
in the 30S ribosomal subunit due to C+ to C- substitution of the r-protein, S14. During our investigation
of ribosome hibernation as a specific response to zinc starvation, we discovered a zinc-sensing Mpy-
recruitment factor (Mrf), that ensures Mpy recruitment to C- ribosome. The mechanism by which Mpy
is recruited to C- ribosomes, resulting in ribosome hibernation, remains unknown. In this proposal,
we will specifically focus on: a) deciphering the mechanism of Mpy recruitment to the ribosome, and
b) identifying the mechanistic basis for Mpy-dependent and -independent drug resistance in
mycobacteria expressing C- ribosomes. The findings will expand our understanding of antibiotic
tolerance associated with ribosome remodeling and hibernation in zinc-starved mycobacteria. Given
that lung environment of Mtb in humans is likely zinc-limiting, our findings will inform and improve the
therapeutic strategies for TB, possibly leading to a shorter treatment regimen.

Public health relevance
Project Narrative There is an urgent need for a shorter treatment regimen for tuberculosis (TB), an infectious disease caused by Mycobacterium tuberculosis (Mtb). To accomplish this challenge, it is necessary to understand the molecular principles underlying antibiotic tolerance in Mtb. In this proposal, we will investigate the significance of ribosome remodeling and hibernation in antibiotic tolerance of Mtb.